Investigating the Role of CDK-2 in Meiotic Recombination

Sexually reproducing organisms rely on proper chromosome segregation during meiosis to ensure the
production of gametes with the complete genetic complement. During meiotic prophase I, chromosomes pair
and undergo chromosomal crossover, an exchange of genetic information between two homologous
chromosomes. This process leads to the formation of physical linkages between the homologs and enables each
chromosome pair to separate during meiosis I. Defects in crossover formation can be disastrous, leading to
aneuploidy and conditions such as age-related infertility, miscarriages, and Down Syndrome. Despite the
importance of this process, the mechanisms governing crossover formation remain poorly understood. The goal
of this project is to determine how crossovers are designated during meiosis to achieve faithful transmission of
genetic information. A recent genetic screen in C. elegans has identified a cyclin-like protein COSA-1 that is
essential for processing meiotic DNA double-strand breaks into crossovers. This finding was subsequently
followed by the identification of its mammalian ortholog CNTD1, which has conserved roles in crossover
formation. However, no CDK has been identified as a binding partner of COSA-1/CNTD1, and how these cyclin-
like proteins designate crossovers is not known. Recently, I have discovered that the C. elegans homolog of
CDK2 (CDK-2) localizes to the sites of crossovers, raising the possibility that CDK2 might partner with COSA-
1/CNTD1 and function as an active kinase to promote crossover formation. Supporting this idea, mammalian
CDK2 has long been observed at crossovers as well as telomeres. However, due to its telomeric function, CDK2
knockout mice exhibit severe defects in homolog pairing and synapsis, which are prerequisite to meiotic
recombination. Therefore, the role of CDK-2 at crossover sites has remained untested. Here I propose to use C.
elegans as a model system to investigate the conserved function of CDK2 in meiotic recombination. Unlike the
mammalian CDK2, CDK-2 is dispensable for homolog pairing and synapsis, but is specifically required for
crossover formation. In Aim 1 I will employ the auxin-inducible degradation system to determine the effect of
CDK-2 depletion on recombination machineries by super-resolution microscopy. I will also determine whether
CDK-2 and COSA-1 form an active kinase complex using purified components. In Aim 2 I will establish the
mechanisms by which CDK2 designates crossovers by identifying its meiotic substrates through both candidate-
based and unbiased chemical genetic approaches. I will then determine the functional significance of CDK2
targets through targeted mutagenesis in C. elegans. Overall, the results of this work will elucidate the conserved
regulatory mechanisms that designate crossovers and will be broadly applicable to higher eukaryotes. Johns
Hopkins University offers a state of-the-art research environment, strong records of post-graduate success, a
vast regional scientific support network, and a wide array of career development programs that make it uniquely
suited for success of my proposed research and career goals.

Public health relevance
Narrative Sexually reproducing organisms rely on proper chromosome segregation during meiosis to ensure the correct inheritance of genomes from parent to offspring. Misregulation of this process is the primary cause of age-related infertility, miscarriages, and genetic disorders, such as Down Syndrome. My proposed research will address the mechanisms by which chromosomes form crossovers, a process essential for meiotic fidelity and genetic diversity. The results of this work will contribute to the discovery of therapeutic interventions in human reproduction and broadly impact diverse fields such as DNA damage repair and cancer.